AMP-AD Brain Proteomic Network Enhancement, Validation, and Translation into CSF Biomarkers

Not applicable for Administrative Supplement.

Public health relevance
Not applicable for Administrative Supplement.